Attachments-free Point and Click Device for the Disabled

DESCRIPTION (provided by applicant): In Phase I of this work, Vortant Technologies created a new point-and-click (VPAC) device for non-invasive computer input. The new device tracks the position and orientation of the user's head, but requires no attachment of devices, markers, or dots to the user. The unique, low-cost "attachments-free" features of the device are possible due to an innovative light-based distance measuring technology. The performance of the Phase I VPAC device significantly exceeded the proposed success criteria. During user evaluation, the new VPAC device performed well, and could be used by nearly all beginners and advanced computer users for basic computer tasks. User feedback questionnaires and interviews showed that users strongly prefer the attachments-free features of the new device, which significantly enhances their level of independence in computer access. The overall aim of the proposed Phase II project is to expand on this foundation to create a VPAC prototype with the look, feel, and functionality of a real-world product. Ergonomic and functional improvements will be made to the device, and a set of VPAC prototypes will be evaluated for usability, including a learning-curve study and a one-month trial.